TRAINING IN THE IMMUNOBIOLOGY AND MOLECULAR CELL BIOLOGY OF CANCER

PROJECT ABSTRACT
This revised application seeks renewal for years 36-40 of a T32 program that will
provide training for 7 postdoctoral MD, PhD or MD/PhD scientists. The training
program is centered in the Department of Pathology and Immunology (P&I) at
Washington University in St. Louis, and consists of 36 training mentors who are
housed in 10 different departments. The training faculty consists of 16 women and
20 men and includes 2 URM. The faculty are a highly interactive group of
immunologists with interests in cancer immunology and cell/molecular cancer
biology and are led by a director and associate director who are well known for their
contributions to cancer immunology/immunotherapy and their commitment to
training of young scientists. The research of our faculty focuses on various aspects
of cancer immunology and immunotherapy with an emphasis on the molecular basis
of cellular activation and suppression. A Steering Committee of six T32 faculty
members oversees the training program and is responsible for the selection and
oversight of the trainees. We also formed a new external advisory board to obtain
outside opinions on our T32 program. Training includes a 2-to 3-year period of full-
time laboratory research, where the trainee is exposed to the latest approaches in
cancer immunology and cell and molecular cancer biology. The training also
includes presenting at laboratory meetings, participation in weekly seminars and
yearly retreats, training in research ethics and rigor and reproducibility, participation
in national/international meetings and opportunities to audit advanced courses in
Immunology, Cell Biology and Cancer Biology. During the most recent 10-year
funding period of this T32, 49 trainees were supported by the Program: 4 withdrew
for personal reasons and 7 trainees who had just started the program had their work
delayed by the COVID-19 pandemic. The remaining 38 trainees published 171
papers with 33 papers appearing in high impact journals and 76% of these trainees
had at least one first-author paper. Of the 70 trainees who have been or are
supported by this Program in the last 15 years, 66 (94%) have remained in research.
These demographics document the success of our T32 Training Program and
provide strong support for its competitive renewal.

Public health relevance
PROJECT NARRATIVE The Training Program in the Immunobiology and Cell Biology of Cancer at Washington University in St. Louis seeks continued support for research training of talented doctors and scientists who wish to pursue careers in discovering basic principles of cancer immunobiology and/or applying their knowledge to the development of novel and more effective cancer treatments. The Program faculty are highly accomplished medical scientists performing state-of-the-art cancer related research in a premier world-class medical research institution with special emphasis being placed on cancer immunology and development of novel cancer therapies. This T32 program has made and continues to make significant contributions to developing the careers of talented young scientists with an interest in the rapidly advancing fields of cancer immunology and immunotherapy.